EVALUATION OF A MONOCLONAL ANTIBODY

The Biopharmaceutical Product Development Services program provides services to facilitate preclinical development of materials that are derived from biotechnology processes.